Adapting acceptance and mindfulness-based behavior therapy for stroke survivors with aphasia to improve communication success, post-stroke adaptation, and quality of life

1 Post-stroke Aphasia has profound and lasting negative effects on health-related quality
2 of life. Aphasia is a language disorder caused by acquired brain injury that affects 30-40% of
3 stroke survivors and more than 2.5 million people in the United States. For stroke survivors with
4 aphasia, their psychosocial response to sudden and unexpected loss of language can inhibit or
5 promote their ability to adapt and adjust post stroke. There is currently a critical need to better
6 address psychosocial factors in aphasia rehabilitation and recovery.
7 To meet this need, the current pilot project seeks to adapt Acceptance and Commitment
8 Therapy (ACT) for stroke survivors with aphasia by integrating language compensation training.
9 ACT is a behavioral intervention designed to improve psychological flexibility, allowing people to
10 take meaningful action consistent with their values, even in the presence of emotional distress.
11 ACT is an ideal intervention for aphasia, as it promotes a more flexible response repertoire that
12 relies less on verbal communication while reducing self-critical judgments and unhelpful thought
13 processes. Furthermore, Integrating ACT and language compensation training will be more
14 than the sum of its parts. Language compensation training is only effective when generalized
15 to often stressful real-world situations while ACT is only accessible to people with aphasia if
16 language needs are deliberately supported. However, while ACT is effective for stroke survivors
17 and people who stutter, no prior work has adapted ACT to meet the specific needs of
18 people with aphasia, thereby excluding a large and vulnerable subset of stroke survivors.
19 The objective of this proposal is to develop and refine an ACT for Aphasia treatment designed
20 to maximize communication participation, psychosocial adjustment, and quality of life for stroke
21 survivors with aphasia. Aim 1: Collaborate with a Stakeholder Advisory Board to develop
22 and refine an ACT for Aphasia treatment manual via an iterative design process. A two-
23 year sequential cohort design (n=21) will result in a comprehensive, stakeholder-driven
24 behavioral treatment. Aim 2: Establish intervention feasibility and acceptability. Feasibility
25 will be assessed through adherence, recruitment, participation, and completion. Acceptability
26 will be assessed via the Client Satisfaction Questionnaire-8. Preliminary effect sizes for
27 communication participation, psychosocial adjustment, and QoL will inform future clinical trials.
28 Developing ACT for Aphasia is directly aligned with the scope and mission of NCMRR, as it will
29 use a behavioral intervention to addresses the disabling consequences of living with post-stroke
30 aphasia, thereby better meeting the needs of this underserved subgroup of stroke survivors.

Public health relevance
Aphasia is an acquired language disorder often caused by stroke that can have profound negative consequences on communication ability and long-term quality of life. There is a critical need to better address psychosocial factors in aphasia rehabilitation and recovery, and therefore the current the current pilot project seeks to adapt Acceptance and Commitment Therapy specifically for stroke survivors with aphasia. This proposal is relevant to the public health as its long-term objective is to better address the disabling consequences of living with aphasia for a vulnerable and underserved subgroup of stroke survivors.